Phosphodiesterase 4 mediated pathogenic mechanisms in alcohol associated liver disease

PROJECT SUMMARY
This is a proposal for a Diversity Supplement for an assistant professor in University of
Louisville School of Medicine to enhance research training and career development in a new
field of alcohol associated liver disease (ALD). The parent grant for this proposed supplement
examines phosphodiesterase 4 mediated pathogenic mechanisms contributing to the
development of alcohol induced hepatic steatosis and injury. The proposed supplement project
examines the cross talk between hepatocytes and hepatic stellate cells (HSC) via exosomes in
the development of ALD fibrosis. Dr. Gobejishvili (PI of the parent grant), Dr. McClain (mentor,
Director of Alcohol Research Center at UofL) and Dr. Montoya-Durango developed new specific
aims, which are related to Aim 2 of the parent grant. Dr. Montoya-Durango will share his
expertise in exosome research and epigenetics with our research team. This diversity
supplement will allow Dr. Montoya-Durango to enhance his skills and knowledge in a new field
of study. During the Diversity Supplement period, he will: (1) actively participate in experiments
outlined in the proposal, (2) publish at least 3 lead papers, (3) present at the RSA and AASLD
meetings, (4) receive regular individual mentoring on training progress and career goals, and (5)
submit grant applications.

Public health relevance
Public Health Relevance Statement Project Narrative This diversity supplement to R01AA029798-02 will provide funding for University of Louisville School of Medicine faculty Diego Montoya-Durango to conduct research that will substantially add to the parent grant. It also provides funding for his training in a new field of study alcohol associated liver disease and his career development.